CK22-008 Healthcare Modeling Workforce Development Through Washington State University's Resistance Epidemiology Modeling Initiative

PROJECT SUMMARY/ABSTRACT
There is a growing need for well-trained, methodologically sophisticated epidemiological modelers,
especially in healthcare settings. Addressing persistent and emerging healthcare-associated infections
(HAIs) such as S. aureus, C. difficile and C. auris require sophisticated modeling approaches that can
represent the complex and dynamic healthcare environment. The SARS-CoV-2 pandemic has also
demonstrated the need for, and value of, modeling support at the state and local level, as well as within
hospital systems to address the specific needs of a diverse range of stakeholders during a public health
emergency. The proposed project, “Healthcare Modeling Workforce Development Through Washington
State University's Resistance Epidemiology Modeling Initiative” seeks to leverage the growing, modeling and
methods focused, interdisciplinary research programs at Washington State University. These programs
address healthcare-associated infections, emerging infectious diseases, and antimicrobial resistance, and
draw from expertise in epidemiology, statistics, mathematics, and computer science, and have a strong track
record of collaboration with clinicians and policymakers. The proposed project would fund three
epidemiology modeling fellows from a variety of potential academic backgrounds. These fellows will be
engaged in three projects: (1) Understanding the tendency of emerging infectious diseases to accelerate
when they reach the healthcare system (termed “Nosocomial Amplification”), (2) the evaluation of existing
models and model-based guidance for its generalizability to rural and community healthcare settings, and (3)
developing methods to model and simulate within- and between- hospital patient transfer networks, to better
understand how these networks are formed, allow studies that disrupt these networks, and to make often
sensitive data more widely accessible in the form of synthetic networks. Each of these projects touches on
one or more HAIs of public health importance and address several thematic areas including antimicrobial
resistance, patient connectiveness, health equity, outbreak response, simulation of epidemiological studies,
systems approaches and zoonotic diseases. The fellowship program will be led by Dr. Eric Lofgren, an
infectious disease epidemiologist and director of the Resistance Epidemiology Modeling Initiative (REMI), a
multidisciplinary effort to support antimicrobial resistance and healthcare-associated infection research at
WSU. Dr. Lofgren has extensive experience in mathematical and computational modeling of infectious
diseases and specializes in the modeling of HAIs. The proposed fellowship program would give fellows
access to a diverse range of opportunities for collaboration across different academic disciplines and support
for professional development opportunities. With both local and national collaborative ties, the program
would position fellows to become the next generation of healthcare modeling experts.

Public health relevance
Project Narrative Washington State University, through the Paul G. Allen School for Global Health and the Resistance Epidemiology Modeling Initiative (REMI), is proposing a three-person fellowship program aimed at training interdisciplinary graduate students with an interest in modeling infectious diseases in healthcare settings. Fellows will engage in three programs, addressing the containment of emerging infectious diseases in healthcare settings, the generalizability of existing models to rural and community hospital settings, and the modeling of within- and between- hospital patient transfer networks. The results of this work, which involves data from both the Southeast and the Pacific Northwest, will help strengthen the public health workforce by training a new generation of methodologically sophisticated healthcare modelers.